Synthetic rocaglates as promising therapeutic agents for aggressive hematological malignancies

Project Summary/Abstract
Despite the significant advances in therapy development, a large proportion of hematological malignancies,
especially the aggressive types remain incurable. Hence, there is an urgent unmet need for the development of
novel treatment strategies for aggressive hematological malignancies. Rocaglate is a novel class of RNA-
sequence-selective interfacial inhibitor that binds to the pocket formed by the RNA helicase eIF4A and the
polypurine sequences in the 5’UTR of target mRNA. The binding prevents the 43S ribosome scanning and
thus the mRNA translation. This unique mode of action confers several advantages to rocaglate over other
chemotherapeutic agents. First, it determines the high efficiency of rocaglate which acts on the functioning
eIF4As rather than depleting them. In fact, elevated eIF4A expression increased the efficacy of rocaglate
action. Second, mutation-based drug resistance is less likely to develop because rocaglate targets both
eIF4A1 and eIF4A2, and the mutations on one isoform, is unable to abolish rocaglate function mediated by the
other isoform. Third and also most importantly, this unique mode of action enables rocaglate to preferentially
inhibit mRNA translation of many critical oncoproteins possessing complex 5’UTR (selectivity and multi-
targeting). We have demonstrated that multiple critical oncoproteins, especially the cell cycle regulators as well
as the transcription factors which are usually considered as “undruggable” proteins, were substantially
repressed by rocaglate treatment in aggressive B-cell lymphomas. One possible reason is that many critical
oncogenes have complex 5’UTR ensuring the tight regulation of their translation in normal conditions, which
makes them highly susceptible to rocaglate treatment. Moreover, cancer cell dependent oncogenes are
commonly actively translated in order to sustain the increased cancer cell metabolism and uncontrolled tumor
growth; and thus cancer cells addicting to these oncogenes would be more vulnerable to rocaglate mediated
translation inhibition than normal cells (synthetic lethality). We therefore hypothesize that rocaglate is a
promising and potent therapeutic agent for aggressive hematological malignancies through directly targeting
the translation initiation of actively translated disease-specific driver oncogenes. In this proposal, we will first
dissect the anti-cancer mechanism of rocaglate by probing rocaglate preferential targets in various type of
hematological malignancies and identify the most sensitive types of hematological cancers to rocaglate
treatment. Then, we will test the therapeutic efficacy and toxicity of a newly developed synthetic rocaglate,
eFT226, in multiple preclinical patient derived xenograft models of aggressive hematological malignancies.

Public health relevance
Project Narrative Despite notable therapeutic advances, many aggressive hematological malignancies remain incurable using concurrent therapeutic regimens; therefore, there is an urgent unmet need for the development of better therapeutic strategies with novel mechanism of actions. Rocaglate is a type of RNA-sequence-selective interfacial inhibitor with high potency and considerable selectivity in inhibiting the mRNA translation of various actively synthesized oncoproteins and we have demonstrated that multiple critical oncoproteins were repressed significantly by rocaglate-mediated translation inhibition in aggressive B-cell lymphomas. Herein, we will dissect the anti-cancer mechanism of rocaglate through profiling rocaglate targets and we will also evaluate the therapeutic efficacy and toxicity of a newly developed synthetic rocaglate, eFT226, in multiple preclinical models of hematological malignancies.